Approaches to Curtail Endometrial Cancer Incidence and Mortality

ABSTRACT
Endometrial cancer incidence rates continue to rise, and it is the most common gynecologic cancer among
women in the US. Distressingly, unlike most other cancers, the survival rates have been stagnant over the last
several decades. There is a significant racial disparity in survival, with non-Hispanic black women having the
poorest outcomes regardless of stage at diagnosis or histologic subtype. The reasons for this disparity, as well
as other gaps in knowledge, such as approaches to monitor high risk women, or understanding survivorship
issues, stand in the way of reducing the burden of endometrial cancer. This symposium will bring together
experts from the fields of epidemiology, biology, pathology, oncology, genetics, and clinical practice to
exchange knowledge and ideas. The discussions generated at and from this symposium will guide research to
reduce incidence, morbidity and mortality from this disease.
We plan a two-day symposium to be held in Detroit, Michigan, in June 2020. There will be seven sessions on
specific topics, each with three to four speakers and a discussion leader. At the end of the second day, there
will be group discussion sessions to develop priorities for future research that will identify the research
initiatives that will have the greatest impact on reducing risk and improving survival from this common disease.

Public health relevance
PROJECT NARRATIVE Endometrial cancer is the most common gynecologic cancer among U.S. women and one of the few cancers that continues to rise in incidence. As concerning are the stagnant survival rates and the large racial disparities in survival after a diagnosis. This symposium will bring together experts in epidemiology, molecular biology, pathology, and gynecologic oncology, along with endometrial cancer survivors to review the current state of knowledge and develop a list of priorities for future collaborative research.